University of Michigan Neuroscience Undergraduate Research Opportunities (NURO)

Project Summary
For undergraduates, intensive summer research programs are a primary means of access to rigorous research
training. While these opportunities can be transformative, extended research experiences enhance learning
and student engagement, better preparing participants for postgraduate training. In this proposal, we seek to
expand the summer research program to include a part-time research component during the academic year
through the Neuroscience Undergraduate Research Opportunity program, conducted within the Neuroscience
Graduate Program (NGP) at the University of Michigan. Participants will be recruited from regional partner
institutions to partake in a 10-week full-time summer program that will continue part-time throughout the
academic year to extend their experience, strengthen mentoring relationships, and increase the significance of
their research contributions. Our primary goal is to prepare undergraduates for long-term research careers in
basic or clinical neuroscience research through 1) hands-on research experience, 2) professional
development, and 3) communication training, all within a highly integrated year-long program.
As collaborative, interdisciplinary research is a hallmark of the NGP, participants will undertake well-defined
research projects that span our program’s overlapping subdisciplines, conducted alongside NGP faculty with
strong mentoring track records. Engaging and interactive workshops will help build transferable professional
skills in areas such as critical thinking, research rigor and reproducibility, navigating barriers to success, and
topics that address a “hidden curriculum”. Scientific communication skills will be developed through our novel
applied improvisation course and weekly mini-presentations, intended to build confidence and agility in public
speaking for use in the lab and beyond. Additional pedagogical methods, such as journal clubs, career panels,
and seminars from investigators with diverse social identities and research interests, will reinforce the
interdisciplinary nature of neuroscience and our culturally aware approach to neuroscience education.
Participants will also be encouraged to join existing NGP programs and workshops which will further foster
interactions between participants, program faculty, graduate students, and other undergraduate researchers.
This novel extended experience will immerse participants in the ecology of a research environment with
numerous scaffolds to support success, wellbeing, mentorship, and growth, placing each student on a solid
upward trajectory toward long-term careers in basic and translational neuroscience research.

Public health relevance
Project Narrative Undergraduate research experiences often serve as an onramp toward long-term research careers, and for many students, intensive summer research programs are a primary means of access to rigorous training in research. In this proposal, we seek to expand the summer research experience to include a part-time component during the academic year with the goal of enhancing student engagement and hands-on learning, as well as better preparing undergraduates for long-term neuroscience careers. This novel extended experience will immerse participants in the ecology of a research environment with numerous scaffolds to support success, wellbeing, mentorship, and growth, placing each student on a solid upward trajectory toward long-term careers in basic and translational neuroscience research.